Imaging Viral Immunity

Vaccines have led to many of the world's greatest public health triumphs, but many deadly viruses, such as HIV, elude the best efforts to develop effective vaccines. An improved understanding of how the immune system operates during a viral infection is critical to designing successful anti-virus vaccines, particularly those designed to elicit T cells, which have the ability to kill virus infected cells before progeny viruses are produced. Many vaccines are delivered in the skin or muscle, where they initiate immune responses in draining lymph nodes. To better understand how live virus vaccines activate T cells, we are using a multiphoton microscope to visualize the interaction of T cells with viruses in living mice. This year our studies have demonstrated distinct locations and effector roles for innate and adaptive immune cells in clearing a poxvirus skin infection.